Creating a low cost open source operant box

We aim to create a low cost (<$100) operant training box, using open source tools and software. Operant training is a highly valuable form of behavioral testing that can assay motivation, impulsiveness, anxiety, depression, addiction, and many other behavioral processes. Unfortunately, most commerical suppliers provide chambers that cost on the order of $5-10K per chamber, once all software and hardware is accounted for. This is prohibitively expensive for many researchers, so we would like to develop a low cost solution that will allow our selves, our collaborators, and any other interested researchers access to this form of behavioral testing.